COBRE Phase III Transitional Center

PROJECT SUMMARY/ABSTRACT
The Center of Research Excellence in Natural Products Neuroscience (CORE-NPN) at The University of
Mississippi School of Pharmacy (UM), initiated ten years ago through a COBRE grant, has developed a
multidisciplinary team committed to evaluating the effects of natural products on the central nervous system
(CNS). The Center now has the potential to develop and sustain an innovative and independently funded
research center focused on treating disorders associated with the nervous system. Faculty in the Center and its
academic home, the School of Pharmacy, have already reported groundbreaking observations on the roles of
cannabinoids and non-cannabinoids in the etiology of weight control, the control of the immune system, treatment
of cancer, control of nausea and vomiting in patients receiving anti-neoplastic treatment, glaucoma, and the
development of sigma receptor agonists in the treatment of cocaine and methamphetamine abuse. Also, CORE-
NPN-supported investigators have increased their competitiveness by attracting extramural funds and publishing
in leading journals of neuroscience. The Center will continue to provide an excellent environment for junior and
mid-level investigators through the Pilot Project Program. Investigators will work in close collaboration with
leading national centers and scientists studying natural products to carry out the proposed projects that build on
these novel insights into the pathophysiology of nervous system disorders. To achieve the goal of establishing
an innovative and multidisciplinary Center focused on the use of natural products to manage
neuropharmacological disorders, the following Specific Aims are proposed: Specific Aim 1: Administration. To
enhance a sound administrative structure that offers strong mentoring for junior scientists, management of the
Research Cores, workshops on grant writing/management (pre- and post-award), training in responsible conduct
in research, intellectual property development, distinguished lectureship program, and promote the development
of the CORE-NPN into an independent Center. Specific Aim 2: Research Core Facilities. To accelerate the
research of the CORE-NPN and the associated community through state-of-the-art equipment, cutting-edge
techniques, and scientific expertise. Specific Aim 3: Pilot Project Program (PPP). To advance an infrastructure
of developmental programs that engage in basic, translational, and entrepreneurial research.

Public health relevance
PROJECT NARRATIVE The focus on natural products in neuroscience and projects examining integrated models, along with outstanding Center faculty, training opportunities, a Pilot Project Program and generous support by the UM administration will ensure the continued growth of a research center that is innovative, multidisciplinary, and moving strongly toward independent funding, along with the development of a core of new and senior neuroscience faculty.